EFFECTS HUMAN GROWTH LEUCINE AND PROTEIN METABOLISM IN NORMAL HUMANS

Whether pharmacologic doses of the anabolic hormone growth hormone can offset the protein catabolic effects of pharmacologic doses of glucocorticoids.